Pilot Randomized Controlled Trial of the Mobile Intervention for Suicidal Thoughts

Given the dramatic increase in Veteran suicide rates in the past two decades, there is a clear need to
develop innovative and effective interventions to prevent Veteran suicide. Use of mobile health (mHealth)
technology could provide a low-cost method to increase the reach of suicide prevention interventions to
Veterans with suicidal ideation.
One of the factors that contributes to suicide risk is what is known as a “suicidal belief system.” This
belief system is made up of several cognitions, including hopelessness, thwarted belongingness, perceived
burdensomeness, unlovability, unbearability, and unsolvability. These cognitions have all been associated with
suicide risk among military personnel. Modification of these cognitions may reduce suicidal thoughts and
behaviors. Our team has developed a brief mobile intervention entitled the Mobile Intervention for Suicidal
Thoughts (MIST) that uses evidence-based interpretation bias modification techniques to reduce these suicide
cognitions. The goal of this project is to is to conduct a pilot trial of the MIST intervention to evaluate whether it
is feasible an acceptable as an adjunct treatment for Veterans with suicidal ideation.
A pilot randomized controlled trial (RCT) is proposed, in which 50 Veterans with suicidal ideation will be
randomized to either MIST plus Treatment as Usual and Safety Planning versus Treatment as Usual and
Safety Planning. The central hypothesis is that Veterans will find MIST acceptable and will be willing to use it to
reduce their suicidal thoughts. The proposed research project will address the following Specific Aims: Aim 1:
Evaluate the feasibility and acceptability of MIST as an adjunct treatment for Veterans with suicidal ideation.
Aim 2: Evaluate the association between contact-time with the MIST intervention and change in suicidal
cognitions; and Exploratory Aim: Assess preliminary group effects of the MIST intervention on suicidal
thoughts/behaviors and functional outcomes.
If shown efficacious, the public health impact of the MIST application could be enormous. MIST would
provide clinicians and Veterans with an easily accessible treatment option to reduce suicidal cognitions and
suicidal ideation, and improve functioning. This low-cost, easily implementable, intervention would significantly
increase the reach of evidenced-based suicide prevention tools.

Public health relevance
Veterans are over 50% more likely to die by suicide than their civilian counterparts. There is a clear need to develop innovative and effective interventions to prevent Veteran suicide. There are several types of beliefs that have been associated with suicide risk, including hopelessness, feeling like you do not belong, feeling like a burden on others, feeling unlovable, feeling like things are unbearable, and feeling like your problems are unsolvable. Modification of these beliefs may reduce suicidal thoughts and behaviors. An efficacious mobile intervention to target these beliefs may be life-saving for Veterans.